Palliative care needs and outcomes for dementia patients

The number of people living with dementia worldwide, estimated at 35.6 million in 2010, is set to nearly double
every 20 years, reaching 65.7 million in 2030, and 115.4 million in 2050.
The World Health Organization has
declared dementia a public health crisis and issued a call for global nations to make dementia an international
public health priority. Dementia is a terminal disease and was the sixth leading cause of death in the US in
2014. Little is known about the everyday lived experiences and suffering endured over time by patients in the
early stages of dementia as most research focuses on patient experiences in the later stages of dementia and
often on those who are already institutionalized. However, patients early in the dementia trajectory are beset
with distressing symptoms. Three out of four Persons With Dementia (PWD) live in the community (e.g.,
private residences or non-nursing home residential care facilities). Proactive, patient-centered palliative
interventions will better prepare patients and families for the challenges of living with dementia in the
community. Implementing early palliative care will facilitate ongoing assessment and management of the
distressing symptoms experienced by PWD from very early in the illness trajectory and result in better
symptom management, quality of life and timely advance care planning. The Stanford Alzheimer's Disease
Research Center (ADRC) was founded in 2015 and we have enrolled a large (and growing) panel of
participants whom we follow longitudinally until death. Recognizing that the primary components of palliative
care include symptom assessment and management, advance care planning completion and provision of
support with end-of-life decision-making, we have designed, refined, and piloted an intervention to be used in
the proposed Randomized Clinical Trial (RCT). We will recruit 200 Stanford ADRC participants and randomize
100 each to usual care (UC) or usual care plus an early palliative care intervention (EPC) to be delivered by a
nurse over a twelve-month period. The EPC will include one nurse-led palliative consult in a two-hour house
call and followed by 11 monthly 30-minute phone assessment plus usual care. The specific aims of the RCT
are (i) To determine whether EPC will lead to lower symptom burden, higher quality of life, lesser resource use
(e.g. hospital admissions and days, emergency visits) & greater patient activation; (ii) To use all the baseline
standardized evaluation measures established by the National Alzheimer's Coordinating Center (NACC) that
are routinely collected on our ADRC participants to identify moderators and mediators of treatment outcome
and (iii) To use mixed-methods to analyze the audiotapes of the encounters between the research nurse and
the patient during the twelve intervention sessions and to assess whether the information that is provided to
participants differs by patient ethnicity and cognitive levels. This RCT provides a very rare opportunity to
monitor the palliative needs over time of community-dwelling ADRC participants and has great potential to
inform future studies by our sister ADRCs on the palliative needs of persons with dementia.

Public health relevance
Currently almost 5 million Americans suffer from the distressing symptoms related to dementia and this number that will triple by 2050. The overall goals of the proposed project are to evaluate, in community- dwelling Alzheimer's Disease Research Center participants the benefits of a 12-month nurse-led early palliative intervention on symptoms, quality of life, health care resource use. The relevance of this research to public health is that there is an urgent need to improve the palliative care of persons with dementia living in the community. This study will contribute substantially to that effort.